Genetic Variation in Cancer Risk and Outcomes in African Americans

Project Summary/Abstract—Overall Program
Genetic testing for both germline and somatic mutations has improved our understanding of the basic biology of
carcinogenesis, identified high-risk populations for targeted prevention and screening, identified targets for new
treatment strategies, and has led to some of the most significant inroads in reducing cancer burden. Yet, there
is still much to learn about the role of inherited genetic susceptibility and cancer, and the significant barriers to
accessing genetic counseling and testing services, particularly in under-represented populations. We have
assembled one of the largest populations of African American cancer survivors to date to study genetic
susceptibility in this population. The Detroit Research on Cancer Survivors (ROCS) (U01CA199240) cohort
includes participants considered to be at particularly high-risk due to family history of cancer, age at diagnosis
or a diagnosis of a second primary cancer, and the infrastructure will be used to expand participation. The
Program includes three projects and two cores with an overall goal of improving the identification and
clinical management of hereditary and multiple primary cancers in African Americans, who are currently
underrepresented in genetic research. To do this we will: 1) Use bioinformatic analyses, family structure, gene
expression, and somatic alterations to identify African American cancer survivors most likely to harbor high-
penetrance genetic variants currently classified as pathogenic or having uncertain significance; 2) Characterize
the spectrum of germline genetic variation in African Americans with multiple primary cancers in relation to known
pathogenic mutations, site-specific polygenic risk scores (PRS), and largely modifiable non-genetic risk factors;
and 3) Develop an online, culturally adapted educational intervention to increase access to genetic counseling
information among medically underserved African Americans and uptake of risk-appropriate genetic testing
among those at increased risk so that we are poised to translate novel genetic discoveries into clinical practice.

Public health relevance
Project Narrative/Relevance—Overall Program The identification of genetic contributors to cancer will help identify high-risk groups and support the development of new treatments, as well as refine prevention and screening guidelines. However, even with our current knowledge of susceptibility genes and the expected novel discoveries, there are significant barriers to getting genetic counseling and testing, particularly in the African American population. Until we can overcome these barriers, the implementation of clinical testing will be difficult, therefore the development of novel strategies to overcome barriers to testing will be essential in reducing cancer burden and health disparities.